Central metabolism of Salmonella in the inflamed gut

PROJECT SUMMARY
Infection with non-typhoidal Salmonella enterica serovars is a common cause of inflammatory diarrhea.
Intriguingly, intestinal inflammation drives an expansion of the Salmonella population in the gut lumen. Prior work
in mouse colitis models has defined mechanisms of how inflammation-driven changes in metabolite availability
support Salmonella colonization in the large intestine through a respiratory metabolism. Due to limitations of the
animal models, these prior studies have focused on the large intestine, however, human disease primarily afflicts
the terminal ileum. We have developed a murine model of Salmonella-induced ileitis, which recapitulates a key
aspect of non-typhoidal Salmonellosis in humans, i.e., neutrophil-dominated ileitis. In this application, we
hypothesize that non-typhoidal Salmonella relies on a tissue-specific, inflammation-adapted carbon and energy
metabolism to facilitate colonization; conversely, we hypothesize that inhibition of this metabolism decreases gut
colonization, disease, and fecal shedding. We will test key aspects of our hypothesis by pursuing the following
specific aims: Aim 1: Determine the carbon and energy metabolism of Salmonella in a mouse model of ileitis,
and Aim 2: Determine whether pharmacological inhibition of anaerobic respiration alleviates features of non-
typhoidal Salmonellosis. This work will advance our understanding of how intestinal pathogens, such as
Salmonella, adapt their carbon and energy metabolism to colonize the mammalian intestinal tract with a
particular focus on the ileum. We envision that a better understanding of the mechanisms by which Salmonella
outgrows competing microbes during inflammation will aid the development of new and innovative approaches
for treatment, and idea we will be pioneering in this application.

Public health relevance
PROJECT NARRATIVE Non-typhoidal Salmonella serotypes are a common cause diarrheal disease in the United States, with a cost of $0.5 to $2.3 billion per year due to lost productivity and the cost of medical care. This application will support studies on how Salmonella colonizes the mammalian intestinal tract and causes disease symptoms. A better understanding of how Salmonella acquires nutrients during infection is expected to aid in the development of new intervention strategies.